High-resolution localization of the hair cell mechanotransduction channel components by immunogold-scanning electronic microscopy

SUMMARY
Our long-term goal is to understand at the molecular level how hair cell mechanotransduction works and why it
fails in different types of hearing loss. Our strategy is to study genes that cause hearing loss in humans by
modeling them in mice. A critical aspect of this research relies on localizing deafness proteins at cellular and
subcellular levels in the inner ear. In the hair cell mechanosensory organelle, known as the hair bundle, high-
resolution localization of proteins provides critical information for defining their functions. For example, the
mechanotransduction machinery itself is organized asymmetrically along the tip link ends. Tip link
nanofilaments transmit the deflection force from taller stereocilia to the tips of paired, shorter stereocilia in
order to gate the channel. Therefore, a protein localized at the upper tip-link insertion complex indicates a
potential role in tip-link tension maintenance. In contrast, a protein localized at the lower tip-link insertion site
suggests a role with the mechano-electrical transducer (MET) channel complex.
High-resolution protein localization is routinely achieved by immunogold-labeling of samples, which are
subsequently embedded, sliced, and imaged using transmission electron microscopes. However, this
approach is massively time-consuming and not suited for extensive quantification. An alternative approach
images the surface of immunogold-labeled samples using scanning electron microscopy (SEM), however this
method is limited to investigating extracellular proteins. As many proteins of the hair bundle are internal but in
the vicinity of the membrane, we hypothesized that immunogold-SEM could be adapted to localize these
internal proteins. Such a technical improvement would allow localization of protein distribution at the nanoscale
from large numbers of hair cells, resulting in increased sample numbers for stronger quantification.
In Specific Aim 1 of this proposal, we will finalize our immunogold-SEM protocols dedicated either to
localizing internal proteins beneath the stereocilia membrane or proteins integral to the stereociliary
membrane. Our preliminary data show that the internal actin-binding protein, EPS8, maintains its
characteristic enrichment at the tip of the tallest stereocilia. At the same time, the hair bundle structure and its
links are preserved. To test our membrane protein method, we will localize transmembrane protein PMCA2a.
In Specific Aim 2, we will capitalize on these immunogold-SEM protocols to locate the
mechanotransduction channels at nanoscale resolution. The protein distributions of TMC1, TMC2
(participating in the pore), and TMIE (required for TMCs activity), will be mapped at the tip of transducing
stereocilia. The MET channel location, expected to be at the intersection between the TMCs and TMIE
distributions, and its distance to the tip link will be measured. Overall, we expect to provide not only the first
nanoscale map of the MET channel components, but also a seminal technique valuable to many other
research fields such as cell adhesion, planar cell polarity, ciliopathies, and axon guidance among others.

Public health relevance
NARRATIVE The intracellular and sub-membranous distribution of proteins often suggests their molecular interactions and physiological functions, which are critical when studying diseases. We have developed a technique for high- resolution localization of internal protein epitopes using immunogold-Scanning Electron Microscopy – a method that has been restricted to extracellular molecules. This technique will not only allow us to localize and study the mechanosensitive ion channel activated by sound in the inner ear with nanometric resolution, but we believe, will also become a seminal tool for the broad scientific community, allowing proteins under the plasma membrane to be located in a fast, quantifiable way.